Biorepository and Tissue Biomarker Technology Shared Resource

Biorepository and Tissue Biomarker Technology Shared Resource:
Summary/Abstract
The goal of the Biospecimen and Tissue Biomarker Technology Shared Resource (BTBMT) is to support the
life cycle of high quality biospecimens for cancer research. The BTBMT is a result of the strategic
reconfiguration of three previous Shared Resources: the Tissue Core, the Immunohistochemistry (IHC) &
Molecular Pathology Core, and the Mouse Pathology Core.